GenSyn: A Cycle for Serial Assembly of Very Large DNA Molecules

Abstract
The broad, long-term objectives of the proposed research are development of a system for
direct, cell-free, validated fabrication of very large DNA assemblies, for applications in synthetic
applications and genome assembly. This system – “GenSyn” – will harness the advantages of
large DNAs for synthesis on supports in ways that will complement and synergize cell-based
techniques for the serial assembly of very large DNA molecules. The proposed research is
based on i) binding approaches supporting chemical and enzymatic processes; ii) shear-free
fluidic operations; iii) new methods for enhancing hybridization/ligation yields and iv) validations.
The devices are designed for gentle fluidic operations supporting assembly and image analysis
of large DNA constructs by epifluorescence microscopy. The first step in the GenSyn cycle will
be binding DNA molecules to a support by hybridization with oligonucleotides that are bound to
a derivatized glass surface. The hybridization and ligation steps will be optimized using physical
and chemical manipulations. Modified large DNAs will be used as coupler molecules, supporting
GenSyn cycles. Overall cycle performance metrics (coupling yields as a function of cycle
number, molecule breakage, reagent retention, timings and enzymatic activity) will be assessed
in ways that will inform and be guided by computer models. This research will help advance
fundamental studies on genomes and human health.

Public health relevance
Narrative A human genome has 46 DNA molecules, some many inches in length, and when laid end-to- end they span almost 6 feet in length. Consequently, it is now impossible to make human genomes in the laboratory. This challenge will be met by greatly simplifying genome manufacturing through new large-scale chromosome construction technologies that assemble large “chunks” of DNA into chromosome-sized molecules by directly harnessing the very intrinsic physical properties that make them “difficult” objects to deal with.